Integration of Biomedical Ontologies with Deep Learning AI for Research and Diagnosis of Rare Diseases

Rare diseases collectively impact more than 30 million individuals in the United States and 300-400 million
individuals worldwide. There are an estimated 7-10 thousand known rare diseases, of which approximately
80% have a genetic etiology. Although important, genetic sequence data alone is insufficient to determine
mechanism and diagnosis of rare genetic disorders (RGDs). In-silico variant pathogenicity prediction and
phenomic information are also critical, though even with these, diagnostic rates remain frustratingly low. Novel
research paradigms, such as a gene-to-patient approach that samples individuals with high confidence in-silico
predicted pathogenic variants from large databases and asks if they share a common phenotype could
promote novel discovery and improve diagnostic rates; however, this approach is hampered by the inability to
easily extract phenotypic information from unstructured data and reliably identify a shared phenotype among
individuals. RGD research that combines genomic and phenomic with other ‘omics’ data also has potential for
improved diagnostic yield and mechanistic understanding; however, these endeavors face significant
obstacles, notably a dearth of multiomic data fusion and analysis methods. Practical RGD clinical diagnosis
additionally requires patient specific diagnostic pathways, the lack of which has resulted in unacceptably
complex and lengthy diagnostic odysseys that places significant burden on individuals suffering with RGDs.
Our proposal addresses these critical limitations through novel artificial intelligence (AI) method development
that will integrate information rich biological ontologies with multiomic data. We will first extend graph neural
network node representation learning methods and develop a custom genetic search algorithm to enable
discovery of a shared population phenotype among individuals in the absence of a disease specification, thus
enabling a gene-to-patient research paradigm. We will further apply these methods to integrate node
representations for a tissue-to-gene expression knowledge graph with genetic sequence data and clinically
accessible tissue (CAT) transcriptomic results in a transformer based deep learning model to predict tissuespecific aberrant splicing pathogenicity. Finally, we will combine these methods in a pilot clinical decision
support system to recommend personalized genetic testing and clinical tests to support RGD diagnosis. This
pilot system will leverage large language models anchored to biological ontologies to enable clinicians and
patients to pose questions regarding reasoning, benefits, and risks of recommended clinical tests in an
efficient, flexible, conversational form. In combination, these outcomes will dramatically improve researchers’
ability to utilize multiomic data to elucidate the mechanisms by which variants affect phenotype and guide
clinicians in the diagnosis and care of individuals with RGDs, thereby substantially reducing patient burden and
improving health outcomes.